Precision mapping of Parkinson's Disease pathophysiology in the Somato-Cognitive Action Network’s DBS targets

: Parkinson’s Disease (PD) is a neurodegenerative disease that causes symptoms
such as tremor, bradykinesia, and freezing of gait, as well as sleep disturbance, autonomic dysfunction, and
abulia. PD patients particularly struggle to initiate and maintain actions, which causes gait freezing, leading
to falls. PD results from dysfunction in motor circuitry, including connections between subcortical structures
such as substantia nigra and striatum, as well as primary motor cortex, which drives voluntary movement.
Recently, our group rewrote the textbook diagrams of motor circuitry. We described a previously
unrecognized Somato-Cognitive Action Network (SCAN) which is interspersed between effector-specific
regions of primary motor cortex (foot, hand, mouth) (Gordon et al., Nature, 2023). The SCAN is engaged by
coordinated rather than isolated actions, and it is strongly preferentially connected to other cortical regions
important for action planning and control, autonomic function, and arousal.
Many SCAN functions (drive to act, gait, autonomic control, arousal, motor coordination) are affected
in PD. Further, clinical targets for neuromodulation in PD are connected to SCAN. Thus, SCAN dysfunction
might be an important aspect of PD pathophysiology and resulting symptoms. Critically, recent technical
advances in noninvasive functional neuroimaging allow us for the first time to reliably evaluate the
connectivity of motor systems, including SCAN, into the deep subcortical structures most relevant for PD.
Using these patient-oriented techniques, we will first test whether PD-relevant subcortical
structures—including clinical targets for PD—are connected more strongly to the SCAN circuit than to
effector-specific M1 foot, hand, and mouth regions. We will then test whether these subcortical-to-SCAN
circuits are altered in PD patients to a greater degree than effector-specific circuits. .
This work will advance a new conceptualization of PD as a disorder of SCAN rather than of traditional
effector-specific M1, which will revolutionize how we think of the disorder. Localizing PD disruption to
specific portions of M1 could aid with evaluation of patients using these advanced, noninvasive fMRI
techniques, and can provide precision targets of interest for other imaging modalities. Noninvasive mapping
of cortico-subcortical connectivity will enable optimal target definition for neuromodulatory treatment of PD.
Reconceptualizing PD as a disorder of SCAN, a system for integrated action, rather than of M1 circuits for
isolated movement, may spur development of alternate symptom evaluation tools oriented around this
framework. Finally, localizing M1 sites of disruption in PD opens the possibility of treating PD using cortical
stimulation, a less-invasive alternative to deep brain stimulation.

Public health relevance
PROJECT NARRATIVE: Parkinson’s Disease (PD) is a neurodegenerative disorder caused by dysfunction in both subcortical structures and cortex. We recently discovered a new brain system called the Somato- Cognitive Action Network (SCAN), which could be a primary locus of dysfunction in PD. Here, we will use magnetic resonance imaging techniques in PD patients to test whether SCAN is critical for PD. We will determine whether SCAN is connected to PD-relevant subcortical structures, and whether PD patients exhibit altered subcortical-to-SCAN connectivity. If successful, this work will identify SCAN as a specific circuit altered in PD patients that can serve as a new target for future neuromodulatory PD therapies.